Statistical Methods for Biomarkers Identification Using High-resolution Diffusion MRI

PROJECT SUMMARY/ABSTRACT
Parkinson's disease (PD) is a neurodegenerative disease that leads to the abnormalities of patients' movement
and other functions. The current clinical diagnosis of PD cannot accomplish the desired accuracy. Imaging
biomarkers of PD has shown great promising in improving the diagnosis accuracy. Our co-investigators
developed a high spatial resolution diffusion MRI, which can improve the spatial resolution substantially and
diminish geometric distortion. Pioneer studies conducted by our co-investigators identified changes in left side
of substantia nigra of right-handed patients with PD. However, the potential of the data has not been fully
realized due to the lack of appropriate statistical methods for this new type of data. This proposal aims to
develop new statistical and computational tools to identify imaging biomarkers via parameters in the continuous
time random walk (CTRW) model using the high resolution MRI data. Existing statistical methods for the CTRW
model did not take the advantage of the high resolution data. The proposed statistical methods will perform high
dimensional inference to integrate the information from a large number of pixels in the MRI data to achieve the
power that cannot be attained by conventional low dimensional methods. This proposal has two specific
objectives (1 ): develop high dimensional statistical inference methods for the CTRW model using high spatial
resolution diffusion MRI; (2): integrate patients' clinical characteristics, such as disease duration, and
neurological test scores and relevant biological variables such as age and sex, with imaging biomarkers in
improving the diagnosis accuracy for PD. The developed statistics methods will be applied to diffusion MRI data
sets of PD patients collected by co-investigators and their collaborators. User friendly software and
computational tools will be made available for public use.

Public health relevance
PROJECT NARRATIVE The project will provide important insight on imaging biomarkers for Parkinson's disease by developing new statistical and computational tools for the continuous time random walk model with newly available high spatial resolution MRI data. The goal is to produce reliable and sensitive imaging biomarkers for Parkinson's disease to improve the diagnosis accuracy, which offers prospects for disease diagnosis and treatment. The proposed research is relevant to the part of NIH's mission that pertains to developing fundamental knowledge in understanding the function of living systems that will help to reduce the burden of human disability and to protect and improve health.